Natural History of Chlamydia trachomatis genital tract infection in women

Chlamydia trachomatis is a well-recognized PID pathogen for which no vaccine is available. Women are at risk
for reproductive sequelae when infection ascends into the upper reproductive tract, driving inflammatory
processes that trigger immune pathology. However, the bacterial and/or host factors that govern ascension and
subsequent pathology remain unknown. Our long-term goal is to identify biomarkers that identify women at risk
for reproductive morbidity or correlate with protective immunity. We and others have established that
susceptibility to human chlamydial genital infection is mediated by pathogen abundance, co-infection, oral
contraceptives and cervicovaginal microbiota. The overall objective of this proposal is to identify cervical
discriminators of asymptomatic, ascending chlamydial infection and endometritis in women. The central
hypothesis is that overall risk for ascending infection is modulated by local host inflammatory responses,
pathogen fitness and environmental factors mediated by the cervicovaginal microbiome. Our rationale is that
identifying these factors will accelerate rational vaccine design and testing. In a pilot study of women at high risk
for STIs, we demonstrated the potential for unbiased characterization of host, pathogen and microbiome
interactions using transcriptomics and determined that a single cervical specimen was sufficient to detect
clustered host transcriptional profiles reflecting microbiome differences and STI infection. Guided by strong
preliminary data and leveraging ongoing NIH funded research, the following four specific aims will test our
hypothesis: 1) Profile cervical immune response with respect to ascending infection and susceptibility to
reinfection; 2) Profile chlamydial transcriptional activity associated with ascending infection; 3) Profile
transcriptionally active microflora in Chlamydia-infected women to determine how these complex microbial
communities modulate ascending infection; and 4) Integrate host, pathogen and microbiome responses to
determine key pathways controlling outcome. The first aim will profile cervical inflammatory responses and
immune cell populations from women with local infection or upper tract involvement in a cohort of highly-exposed
women (TRAC2). We will transcriptionally profile the chlamydial strains causing their infections and use
metatranscriptomics to characterize the contribution of the cervicovaginal microbiome. Finally, we will use robust
biostatistical approaches to improve and expand our understanding of key chlamydia–host interactions that
modulate infection outcomes, drive disease and establish protective immunity. The research proposed is
innovative, in our opinion, because it will implement a comprehensive, non-biased approach to the identification
of molecular biomarkers in a highly disease-relevant clinical population. The proposed research is significant
because it is expected to translate directly to anti-chlamydial vaccine evaluation in humans and to have broad
importance for diagnosis and for evaluation of novel therapeutics.

Public health relevance
Chlamydia trachomatis is the leading bacterial cause of sexually transmitted disease worldwide. The proposed research is relevant to public health because it will lead to new diagnostic biomarkers that can identify women at increased risk of poor reproductive outcomes after infection and identifying people for targeted treatments and more frequent screening. This will reduce the burden of involuntary infertility and improve the health of young people so is well aligned with the NIH’s mission that seeks to apply knowledge to ‘enhance health, lengthen life, and reduce illness and disability’.